Mass Spectrometry Method for Carbohydrate Structure

3 oaae.s) 1Z_ Introduction to SuoDlemental Aoolication (Not to exceed one oaoe) A. SoecificAims ^R-21^ B. Backaround and Sianificance 2J C. Preliminary Studies 2pound D. Research Desian and Methods (R-21) 29 Milestones (R-2V __M__ A. Soecific Aims (R-33) 35 D. Research Desian and Methods (R-33^ 3pound H. Human Subjects 44 I. Vertebrate Animals 44 J. Literature Cited 45 K. Consortium/ContractualArranaements 5J_ Checklist 54 Appendix (Five collated sets. Nopage numbering necessary for Appendix ) Check if Appendix is Appendices NOT PERMITTED forPhase I SBIR/STTR unless specifically solicited. Included Number of publications and manuscripts accepted for publication (not to exceed 10) Other items (list): PHS 398 (Rev. 05/01) Page 3 Form Page 3